Social and Genetic Contributions to Children's Sleep, Health and Functioning

Project Summary
With our ethnically and socioeconomically diverse longitudinal twin study, in this competing continuation we
aim to understand the genetic and environmental mechanisms linking sleep and physical health across
pubertal development. We also elucidate mechanisms accounting for longitudinal associations between these
health processes and both mental health and inflammation in adolescence. Further, we examine a key
proximal sociocultural process - daily media use - which is pervasive in the everyday lives of adolescents. With
inflammation and mental health problems on the rise among youth, it is imperative that we utilize a well-
powered (N=700 twin youth), representative (recruited from birth records), genetically-informed (twin study),
longitudinal (followed since infancy with proposed assessments at 12 and 14 years) design to identify risk and
resilience processes across the major transition from childhood to adolescence. To date, our results suggest
that sleep is linked with cognition and health for genetic rather than environmental reasons (see C1),
suggesting that third variables are involved that may vary by development (puberty). More specifically, we add
two follow ups of a diverse twin sample recruited from birth records and assessed at 1, 2, 5, 8, 9, 10 & 11
years (N=700 youth; Arizona Twin Project). At 12 years, we add new assessments of the environment (e.g.
media use) and extend our objective measures of sleep and health (aerobic, muscular, adiposity, physiology).
At age 14, we add new outcome assessments (inflammatory biomarkers, mental health). Under Aim 1, we use
parallel process growth models from childhood into adolescence to determine direction of effects among
puberty, sleep, and multiple indicators of health. Under Aim 2, we dynamically extend this work by using
intercepts and growth parameters from the parallel process growth models outlined in Aim 1 to predict
inflammation and mental health at age 14. Under Aim 3, we examine the genetic and environmental overlap
among puberty, sleep, and health and pinpoint aspects of the environment that play a role in health. Such an
examination is critical as our work has shown that common risk factors and health are often associated for
genetic as opposed to environmental reasons which can shift the focus of potential interventions. Under Aim 4,
we disentangle genetic and environmental contributions to associations between daily sociocultural contexts,
sleep and health. The proposed study builds on existing collaborations with complementary expertise. The
project is notable as it is the only twin sample of youth to obtain longitudinal objective sleep, health, and
sociocultural context data, for its developmental cultural and genetic approach that uncovers gene-environment
interplay, measurement of physiological and inflammation biomarkers, and examination of proximal
sociocultural processes including objective media use in adolescence. Combining these design features
exponentially increases the scientific contribution, elucidating processes that support preventive intervention
efforts.

Public health relevance
Project Narrative The public health relevance of this project lies in its comprehensive approach to studying the genetic and sociocultural contributions to the development of childhood and adolescent sleep and health in an ethnically and socioeconomically diverse sample. The results yield a better, genetically-informed understanding of developmental pathways among sleep and health during puberty to identify dynamic processes that longitudinally predict mental health and inflammation. The knowledge to be gained informs intervention and prevention through identification of modifiable targets that impact adolescent sleep and health.